NIDCD National Temporal Bone Hearing and Balance Pathology Resource Registry

Abstract The present proposal seeks to transfer the University of Pittsburgh temporal bone collection to Mass Eye and Ear. The University of Pittsburg has entrusted Mass Eye and Ear and the National Temporal Bone Registry to house and preserve the Sando Temporal Bone collection. This collection is one of the largest collections in the world and is of significant scientific value in the study of human hearing and vestibular disorders. It includes 880 trays of stained and a similar amount of unstained sections. There are 265 temporal bones in celloidin with accompanying histories, autopsy reports and audiograms. The case also includes 21 cases of unique coronal sections that include the entire Eustachian tube. We will make this collection accessible to investigators by incorporating the collection into the National Temporal Bone Registry database. Housing the collection at Mass Eye and Ear will also facilitate the digitalization of the histological slides for remote access.

Public health relevance
Narrative As this is a large collection, transfer to Boston from Pittsburgh requires the service of professional movers. To house the collection, we have already installed new cabinets in our existing space, the cost of which is included in this request along with the cost of the movers.